Specialized Translational Control of Stem Cell Differentiation and Embryonic Development

Control of gene expression in space and time plays an important role in enabling cells to “know” where they are in the
developing embryo and what to become, a process often referred to as cellular specification. Decades of research have
demonstrated numerous layers of regulation in control of gene expression, at both the transcriptional and post-transcriptional
level, which coordinate this process. Translational control of gene expression has, on the contrary, received less
experimental attention. Most notably, the prevailing dogma has been that at the level of protein production, the ribosome -
although an immensely complex molecular machine- possesses a constitutive rather than regulatory function in translating
mRNAs. Our findings have established a new field of study by demonstrating that ribosomes are highly regulatory in control
of the expression of developmental gene regulatory networks underlying tissue patterning and formation of the mammalian
body plan. In our most recent studies, we have identified entire biological pathways in embryonic stem cells represented
by the translational preferences of specific ribosomes, that differ in the composition of their ribosomal proteins (RPs) or the
interaction of novel ribosome-associated proteins (RAPs) that we have recently identified that directly associate with
mammalian ribosomes. We have further shown ribosome heterogeneity in proximity to key cellular organelles as a
mechanism to control localized protein production within subcellular space. These findings change our understanding of
gene regulation and open a new portal of study into an additional layer of gene expression vital to control of cell
specification, tissue patterning, and embryonic development. In this proposal we will undertake a highly multidisciplinary
approach to characterize this novel regulatory code for translational control of the circuitry of key developmental networks.
In Aim1 we will extend our new roadmap of ribosome heterogeneity indicated by the presence of distinct ribosomes during
primary human ES cellular differentiation to an organismal level. In particular, we will leverage novel genetic tools to study
ribosome biology in-vivo. Using this approach, we will delineate the mechanisms by which a single RP can control a
paramount step in embryonic development, namely sustained paraxial mesoderm formation, and its role in translational
control of the WNT signaling pathway, which reflects a novel step in the regulation of a major signaling pathway in
development. In Aim2 we will undertake a systems level approach to characterize the role of ribosomes as key regulators
of cell fate transitions. We will utilize novel technologies to forcibly and inducibly remove specific RPs selectively from
cytoplasmic ribosomes for the first time and assess their individual functions on stem cells differentiation down the
mesoderm and endoderm lineages. In Aim3 we will functionally characterize alternative RP paralogs in mammary-glad
development for which our compelling preliminary data indicate that they translate distinct subsets of mRNAs during the
switch to lactation. We hypothesize that translation control is required to synthesize copious milk proteins critical for
neonate sustenance. Defining at a more basic level the specificity and dynamics of ribosome-mediated control gene
regulation will be invaluable for our understanding of how deregulations in the ribosome alter accurate control of gene
expression underlying human congenital birth defects.

Public health relevance
In humans, accumulating evidence links mutations in a number of core ribosome components and in particular ribosomal proteins (RPs) to congenital birth defects, including Diamond-Blackfan anemia (DBA) characterized by specific congenital birth defects including limb abnormalities, cleft palate, growth failure, as well as bone marrow failure. In all of these cases, the mechanism(s) that would account for these cell and tissue specific phenotypes remain poorly understood. Defining at a more basic level the specificity and dynamics of ribosome-mediated control gene regulation will be invaluable for our understanding of how deregulations in the ribosome alter accurate control of gene expression underlying human congenital birth defects.